Integrated Networks of Scholars in Global Health Research Training (INSIGHT)

PROJECT SUMMARY
PROJECT TITLE
Integrated Networks of Scholars in Global Health Research Training (INSIGHT) Program
(5D43TW012274-03)

Public health relevance
PROJECT NARRATIVE The Integrated Networks of Scholars in Global Health Research Training (INSIGHT) consortium formed between the University of Alabama at Birmingham, the Baylor College of Medicine, the University of Maryland Baltimore, and the University of Pittsburgh supports training for the next generation of global health scholars. We have faculty members across our multidisciplinary and multi-institutional consortium working with institutions in the U.S., sub-Saharan Africa, South Asia, Latin America, and the Caribbean. The program’s strategic focus is on a broad range of global health research areas, including combatting the global HIV epidemic and associated co- morbidities, emerging and re-emerging infectious diseases, childhood chronic diseases, and non- communicable diseases. This training in global health research is not just an investment in education—it's a powerful tool for understanding and finding solutions to lower chronic disease rates, improving health outcomes, and making America greater, safer, and more competitive.